Calcium signaling mechanism in proximal tubule underlying calcium nephrolithiasis

Project summary: The prevalence of nephrolithiasis affects more than 10% of Americans in their lifetime.
Veterans’ health records show that nephrolithiasis is one of the leading causes of hospitalizations and is
associated with increased morbidity. Calcium nephrolithiasis (CaNL), which has increased in the past few
decades, comprises ~80% of patient stones. In CaNL patients stones usually consist of calcium oxalate (CaOx)
with variable amounts of calcium phosphate (CaP) as a core component, signifying CaP as the focal point for
CaP+CaOx (mixed) stone formation. Moreover, a recent surge in CaP content from CaNL patients suggests the
further need for research on CaP stone formation. While the exact pathogenesis of initial CaP crystallization is
unknown, it is proposed that the nucleation of CaP crystals starts with the supersaturation of Ca2+ and a relatively
higher pH at the thin descending limb of the loop of Henle (LOH). Importantly, pH >6.5 increases CaP
crystallization and pH <6.2 decreases its solubility. Thus, handling of PT luminal [Ca2+] and pH both can be
critical to the formation of CaP at the LOH. The proximal tubule (PT), immediately upstream of LOH, is the major
site (~70%) for Ca2+ reabsorption, where Ca2+ transport is described as paracellular. We found a transcellular
Ca2+ transport machinery operated by transient receptor potential canonical 3 (TRPC3) Ca2+ channel at the PT
apical brush border area. The mice lacking TRPC3 displayed disrupted Ca2+ transport by PT cells and presented
with intraluminal CaP crystals at the LOH. Thus, our central hypothesis is that the interruption in PT transcellular
Ca2+ transport, via TRPC3, and the rise in pH in PT luminal fluid, are critical to CaP crystal formation at the LOH,
contributing to mixed stone formation. In Aim 1 we will investigate the renal Ca2+ clearance using TRPC3 global
KO and PT-specific TRPC3 KO mice models to define the significance of PT transcellular versus paracellular
Ca2+ reabsorption as well as to sort out the contribution of the TRPC3-mediated Ca2+ transport in the distal
nephron. Importantly, the two main factors that favor CaP crystallization are alkaline urine and hypercalciuria. In
fact, alkalinization of PT luminal fluid due to acidosis in women can facilitate CaP crystallization at the LOH;
conversely, men are predisposed to idiopathic hypercalciuria, which is common in CaNL with mixed stones.
Thus, in Aim 2, we will target the sex-dependent phenotype of CaP and mixed stone formation in our animal
models to determine the susceptibility of CaP and mixed stone formation in response to high calcium diet/urine
alkalization. Finally, in Aim 3 we will determine the impact of microenvironmental stress exerted by vascular
calcification/inflammation on the PT cell function and the detrimental pathway activation to induce CaP and mixed
stone formation in vitro and in vivo. Proposed research will find i) novel molecular targets/mechanism of Ca2+
regulation in the PT and its role in CaNL; ii) the PT-specific mechanism on initial intraluminal CaP crystallization
site; iii) identify a new molecular mechanism handling higher alkaline conditions pertaining to the higher
incidence CaP stone formation; iv) the impact of microenvironmental stress exerted by vascular/immune cells.
These Aims will determine the basis for preventing the formation of CaP and mixed stones towards developing
the therapy for pathophysiology-based intervention.

Public health relevance
Kidney stone disease affects 10% of people over their lifetime, and the incidences are increasing. The rate of recurrence in stones (above 50% within 20 years) is also very high, and over $2 billion dollars is spent annually on the treatment. Veterans’ health records show nephrolithiasis as one of the leading causes of hospitalizations and that it is associated with increased morbidity. The majority (80%) of these calcium nephrolithiasis (CaNL) patients are with mixed stones, composed of calcium oxalate (CaOx) plus calcium phosphate (CaP). Our study will use several animal models to provide a mechanistic link between transcellular Ca2+ transport in the renal proximal tubule (PT) and CaP with mixed (CaP+CaOx) crystal formation as a primary basis for developing CaNL. The proposed study will also uncover the sex-specific dichotomy in pH susceptibility, and the local (PT) microenvironment role towards CaP and mixed stone formation. The outcomes will help to plan and execute translational studies towards the development of therapeutic strategies for CaNL and associated diseases.